Cell and Tissue Imaging Core

Project Summary: Cell and Tissue Imaging Core
The Cell and Tissue Imaging Core will enhance activities and accomplishments of ongoing research projects
by providing histology services, access to a range of advanced microscopic imaging equipment and technical
expertise. It will provide essential resources for microscopic evaluation of ocular tissues and increase the
innovative capabilities of participating investigators for conducting productive basic and translational vision
research. The Core will provide equipment and technical expertise for performing histology, light/confocal and
electron microscopy, and live cell imaging. The specific aims are to provide resources for: 1) performing
histology of ocular tissue specimens; 2) enabling investigators to evaluate ocular tissues with the use of
sophisticated light/confocal and electron microscopy and emerging imaging modalities; 3) training investigators
and their research staff on the utility and operation of cell and tissue imaging equipment; and 4) consultations
on cell and tissue preparation and imaging for experimental design and appropriateness of techniques to
achieve research goals.